Activation of inflammatory programmed cell death by SARS-CoV-2

Project Summary
Programmed cell death is an ancient and effective defense mechanism against intracellular infection: activation
of cellular suicide in response to intracellular pathogens eliminates pathogens’ replicative niches and exposes
them to immune-mediated killing. However, when these responses occur incorrectly or overexuberantly, they
can cause tissue destruction and exacerbate inflammation. Work from many groups including our own has
shown that infection of the lung with RNA viruses can trigger cell death via the inflammatory process termed
“necroptosis.” Our preliminary data confirm that infection of cells of the lung epithelium with SARS-CoV-2 leads
to their death by necroptosis. These findings, along with additional preliminary data contained within the
proposal, lead us to hypothesize that cell death by necroptosis is a key early response to infection of the
lung with SARS-CoV-2. We further hypothesize that while a measured necroptotic response helps to
eliminate SARS-CoV-2 virus, excessive necroptosis in the lung can lead to detrimental inflammatory
pathology. We will test these hypotheses by focusing on three Aims: First, we will carry out detailed
immunological and pathological profiling of SARS-2 infected mice lacking key components of necroptotic
signaling. Next, we will use a mouse model developed in our lab to experimentally induce necroptosis in the
alveolar epithelium in conjunction with SARS-2 infection. Finally, we will use human lung slices to assess cell
death responses to SARS-2 infection in intact human tissue.

Public health relevance
Project Narrative When cells are infected with viruses, one defensive strategy is for these cells to initiate their own death. This “cellular suicide” prevents viral replication and promotes immune responses, but if it occurs too potently it can also drive tissue damage and detrimental immune-mediated damage. This proposals will investigate whether SARS-CoV-2 activates cellular suicide in lung cells, and whether this response contributes to “cytokine storm” and tissue damage in patients with COVID-19.